Cancer Center Administration

Administration Summary
The MCC Administration's expertise in organization and facilitation removes obstacles and barriers to
research, allowing MCC members to focus on science and translation. Under the leadership of new Associate
Director for Administration, Seanne Falconer, MBA, FACHE, Administration drives the human resources,
communications, community engagement, and non-science infrastructural activities necessary to achieve the
mission and vision of the MCC. MCC Administration also conducts rigorous evaluations of progress towards
the goals and objectives of MCC's Strategic Plan and continues to refine and improve practices and processes
to provide excellent, cost-effective services, including the development of multiple grant management
software/database systems. Administration includes 120 employees who provide support for the basic, clinical,
and population research and educational missions of the MCC, as well as for the 229 research members from
53 UMN departments in 13 colleges. MCC collaborates across the UMN to showcase the collaborative
opportunities and research resources of the MCC when recruiting faculty, resulting in the hiring of 33 new
members since 2013. The MCC FY17 budget was $19.5M, including $2.3M (13%) in support from the CCSG.
Recent major achievements by MCC Administration include renovating 7000 ft2 of space to accommodate new
research collaborations; creating a Shared Resource Network in a mutually beneficial partnership with the
Mayo Clinic Cancer Center; establishing the Community Engagement and Education Program to engage and
educate communities about cancer prevention, treatment, survivorship, and clinical research; launching the
Research Development Office to provide proactive services to build strategic capacity; and supporting strategic
initiatives to increase solid-tumor therapeutic clinical trials accruals by 13% in 4 years. The grants
administration team managed and supported the submission of 534 proposals (429 new) since 2013, totaling
over $18 million in direct costs. This research portfolio includes an NCI training grant; an ACS institutional
research grant; multiple U01s; and complex, multicomponent grants, including 5 P01s, a U54, and several
multiple-PI, multi-institution grants. The administration revamped the pilot grant process to ensure that funding
is aligned with the Strategic Plan's priorities, and implemented a return-on-investment (ROI) analysis on all
pilot awards. During the previous grant period, pilot grant investments produced an ROI of 648%, converting
$3.8M in pilot funding into $24.8M in cancer-focused research grants. MCC Administration was integral in the
creation of the Minnesota Cancer Clinical Trials Network, which was designed to improve cancer outcomes by
providing greater access to cancer clinical trials. The State legislature appropriated the initiative $4M annually,
in perpetuity, and MCC immediately established a detailed budget, hired dedicated staff, convened partner
organizations, defined legal contracting aspects of a statewide network, and issued an RFA to award funds to
clinics throughout the state.